Targeting leukemic stem cells in acute myeloid leukemia

Project Summary
Acute myeloid leukemia (AML) is a clonal hematological malignancy with limited therapeutic options. It
originates from and is sustained by a small population of self-renewing precursor cells - leukemia initiating/stem
cells (LSCs). This immortal reservoir of tumor cells displays extremely low proliferation rates and resistance to
current treatments. They are also responsible for relapses. It remains a critical challenge to develop effective
therapeutics to eradicate LSCs. A novel approach focused on the unique characteristics and vulnerabilities of
LSCs is needed in order to address this problem. We previously discovered a bioenergetic stress-induced
differentiation/repopulation checkpoint in hematopoietic stem cells (HSCs) in studying PTPMT1, a mitochondria-
based phosphoinositide phosphatase. Knockout of PTPMT1 decreases mitochondrial metabolism and causes
bioenergetic stress, which in turn triggers a cell cycle checkpoint (AMPK-p21/p57), leading to differentiation-
associated cell cycle arrest in HSCs. Importantly, the survival and self-renewal of these knockout HSCs are not
affected, and their differentiation block is reversible. Our recent preliminary study suggests that a similar
bioenergetic stress-induced cell cycle checkpoint may also operate in LSCs --- the development and
maintenance of oncogene (FLT3-ITD and MLL-AF9)-driven or PTEN loss-induced AML are substantially
inhibited by the deletion of PTPMT1. Interestingly, PTPMT1 depletion induces cell death in LSCs, in sharp
contrast to HSCs. Mechanistically, PTPMT1 loss does not impact mitochondrial structure; rather, it appears to
block mitochondrial utilization of the major metabolic substrate pyruvate, a key metabolite derived from glucose
that lies at the intersection of mitochondrial oxidation and cytosolic fermentation. Based on these observations,
we hypothesize that LSCs can be targeted by inducing bioenergetic/metabolic stress and cell cycle arrest
through pharmacological inhibition of PTPMT1 or mitochondrial uptake of pyruvate, which yields the possibility
of eradicating LSCs. Notably, alexidine dihydrochloride, an antibiotic used as an anti-septic and anti-plaque
agent for dental products, has been identified as a selective and potent PTPMT1 inhibitor, and rosiglitazone
(Avandia), a viable anti-type 2 diabetic drug (previously known as a peroxisome proliferator-activated receptor γ
agonist), has been shown to effectively inhibit the mitochondrial pyruvate carrier/transporter (MPC). As a result,
the novel properties of these drugs will serve as a critical asset for testing our hypothesis. We plan to achieve
the objective of this proposal by pursuing the following three aims. 1). To further characterize the effects of
PTPMT1 depletion on LSCs. 2). To determine the molecular mechanisms by which PTPMT1 depletion inhibits
mitochondrial metabolism. 3). To test for the potential therapeutic effects of the PTPMT1 inhibitor alexidine
dihydrochloride and the MPC inhibitor rosiglitazone in xenograft models of human AML. This project, if
successful, may lead to a novel strategy to deplete LSCs in AML, and the PTPMT1 and MPC inhibitors could be
repurposed and further developed into therapeutic agents for AML.

Public health relevance
Project Narrative Acute myeloid leukemia (AML) is a devastating blood cancer with limited therapeutic options. Relapse is the main cause of treatment failure, most likely due to the persistence of tumor precursor cells (leukemia initiating/stem cells) that are resistant to current treatments. It remains a critical challenge to develop effective therapeutics to eradicate these cells. The project proposed in this application seeks to target the metabolic vulnerability of these cells through inhibition of PTPMT1 that plays an important role in cell energy production. If successful, this effort may lead to a novel strategy to deplete these root cells in AML.